Strategies and Methods for Complex Molecule Synthesis

Summary of Current MIRA Award (R35GM130345) The goal of this program is to develop new strategies and methods for the synthesis of biologically active secondary metabolites (natural products). A significant portion of our efforts is dedicated to identifying efficient preparations of compounds, which, along with their unique derivatives, will serve as novel small molecules to combat a range of indications associated with cancer, inflammation, and pain. Our synthetic studies are focused on C–C bond cleavage methodology, novel enantioselective halogenation and cycloaddition reactions, as well other methods for molecular editing. Our current work also highlights new directions for the use of carvone and pyrone as a sustainable starting material for enantioselective and enantiospecific syntheses. Finally, through collaborations, we will gain unique entry into the use of natural products and their derivatives to perturb biological function and ultimately provide promising starting points for new therapeutics.

Public health relevance
Project Narrative Finding new and more efficient ways to build complex, bioactive, secondary metabolites (natural products) is important as it may lead to improvements in human health by identifying alternatives to existing medications to address, for example, cancer and other diseases associated with inflammation. Our goals are to develop new strategies and methods to efficiently construct complex secondary metabolites by using the carbonhydrogen and carbon-carbon bonds, which have traditionally been viewed as inert. We will also use carvone, a readily available and sustainable agricultural byproduct, as a starting material for many of our syntheses.